ViTrack: Wearable, accurate, continuous blood pressure monitor to improve outcomes in hypertensive diseases of pregnancy

Dynocardia, a Tufts University School of Medicine and Massachusetts Institute of Technology spinoff, is
addressing an unmet need for real-world accurate and continuous non-invasive blood pressure (BP) and other
cardio-hemodynamic parameters. ViTrack™, a unique optomechanical sensor and computer vision
technology, is the first to measure beat-to-beat systolic (SBP) and diastolic BPs (DBP) in real-world settings
with the accuracy of invasive arterial pressure without external calibration, irrespective of subject movement or
wrist position relative to the heart (hydrostatic pressure change). Dynocardia is expanding into the hospital
market and exploring its technology's potential in other areas of healthcare, particularly in maternal health.
Dynocardia has secured an SBIR Phase II grant [Project Number: 1R44HL167356-01] to study the
effectiveness of ViTrack technology in ensuring the safety and well-being of mothers and their children during
pregnancy.
I. Project summary:
ViTrack’s beat-to-beat accurate measurements, irrespective of patient movement or wrist level to the heart,
provide the patient’s circadian BP pattern, including 24-hr mean BP, nighttime BP, and BP variability (BPV). In
addition, ViTrack also measures heart rate, respiratory parameters, and advanced hemodynamics. The
hypertensive diseases of pregnancy (HDP) are a significant cause of morbidity and mortality. The current
standard for measuring BP in pregnant women is the periodic use of oscillometric arm-cuff devices. The
oscillometric devices indirectly estimate SBP and DBP based on artery wall oscillations during cuff deflation.
Measurement errors inherent to this indirect method, patient posture/movement, and wrong cuff size lead to
unreliable BP measurements in 50% of routine office visits. Oscillometric device errors are compounded in
pregnant women due to hemodynamic and vascular changes that reduce oscillations of the arterial wall,
resulting in BP underestimation.
In contrast, these hemodynamic changes will have less impact on ViTrack measurements because it utilizes
pressure-dependent spatiotemporal skin displacement to measure SBP and DBP directly. In addition, random
clinic measurements during antenatal visits lead to a 30% wrong diagnosis of HDP due to white coat or
masked hypertension. In addition, there is a need for remote and continuous accurate measurement of BP for
prediction and early deduction of preeclampsia. The circadian BP parameters, such as 24-hr mean SBP,
nighttime BP, and BPV, are better predictors of preeclampsia than clinic BP measurements. ViTrack, the first
standalone, wearable, connected device, can provide remote, accurate circadian BP data for correct diagnosis
and enable predictive monitoring for better outcomes.
In preclinical, outpatient [vs. auscultatory method], and inpatient [vs. invasive arterial pressure], ViTrack met
FDA standards for accuracy. In this SBIR Phase II study, we are expanding the application of ViTrack in HDP
in partnership with NYC Health + Hospitals that serves underserved populations, a large percentage of them
non-Hispanic Black population at high risk for HDP. The Aims of the study are:
Specific Aim (SA) 1: Assess the accuracy of ViTrack BP measurements (n=48). SA1(a): Determine the
accuracy of ViTrack measurements in pregnant women (n=33) as per the European Society of Hypertension
International Protocol-2010) [34]; SA1(b): Determine accuracy in severe preeclampsia (n=15), defined as BP
measurement of 170/110 or more and proteinuria of 500 mg or more in 24-hr. Milestone: ViTrack accurately
measures BP in pregnant women, including women with severe preeclampsia.
SA2: Assessment of 24-hr BP with ViTrack (n=100). Collect 24-hr BP with ViTrack and intermittent cuff BP
measurements as per standard practice from the contralateral arm; SA2(a): Assess tolerability/usability and
reliability of 24-hr beat-to-beat BP in unconstrained subjects (n=20); SA2(b): Compare the 24-hr BP profile in
pregnant women with and without HDP (n=80); SA2(c): Compare the number of hypotensive/hypertensive
episodes with ViTrack continuous measurements vs. the intermittent cuff measurements. Milestone: ViTrack
provides reliable 24-hr data despite patient movement.
The data generated will validate ViTrack as the first standalone technology for accurate and continuous BP
during pregnancy. This foundational data will inform the commercial build, final clinical validation and FDA
submission, and 510(k) approval for continuous BP measurement in pregnant women. In addition, further
randomized control trials will validate the application of ViTrack in risk prediction, early diagnosis, and
management of preeclampsia and, thus, as the new standard of care for BP monitoring during pregnancy.

Public health relevance
Project Narrative The hypertensive diseases of pregnancy are a significant cause of morbidity and mortality. ViTrack™ is a cuffless, wrist-wearable device that uses a fundamentally new method to accurately and non-invasively measure blood pressure. This study will validate ViTrack as the first standalone wearable device for accurate and continuous blood pressure monitoring during pregnancy.